Phages as Lenses to Study Virus Assembly and Virus: Host Interactions

SUMMARY
Icosahedral capsid assembly is a highly coordinated process involving sequential addition of multiple proteins,
ultimately leading to an infectious virion of proper size and morphology. One long-term goal for this project is to
achieve a mechanistic understanding of the protein:protein interactions involved in capsid assembly. The
development of new anti-viral drugs is impeded by a lack of understanding of how viral capsid proteins are
programmed to adopt the correct conformations to produce the correct assembly product. Capsid assembly will
be investigated using bacteriophage P22, a model dsDNA virus. In phage P22, herpesvirus and many other
dsDNA viruses, the capsid is formed from a coat protein having the ubiquitous HK97 fold. The initial assembly
product is a procapsid (PC). Scaffolding protein (SP) directs proper assembly of coat protein (CP) to form PCs.
SP also directs the incorporation of the portal protein complex, which is essential for genome encapsidation.
Phage P22 provides an excellent model assembly system because complex in vivo processes are easily
mimicked in vitro. The simple genetics and well-established biochemistry of phage P22 offers significant
advantages as an assembly model over complex mammalian dsDNA viruses. Our goals for this project are to
1) reveal how different regions of SP interact with all of the capsid proteins to control assembly and yield of
PCs with the correct morphology, 2) understand the SP structure and arrangement inside of PCs, and 3)
understand the signal relayed by portal protein during DNA packaging that lead to SP exit and the virus capsid
maturation. Another goal is to understand understudied systems involved in P22’s interaction with host cells
and proteins. We will determine the mechanism of superinfection exclusion by P22’s SieA, and the function of
P22’s gp14. 1) SieA prevents the delivery of DNA across the Salmonella inner membrane by P22 and P22-like
phages through interaction with their ejection proteins, which are used to make the genome delivery tube. But
how SieA does this is not understood. 2) P22’s gp14, which is encoded in the structural gene cluster, has no
known function. We have shown that it is a spermidine acetyl transferase, by why P22 codes for this enzyme is
a mystery. A combination of molecular biology, genetic and -omics approaches along with biochemistry and
structural analyses of proteins and particles will be used in the investigation of the assembly process and
virus:host interactions.

Public health relevance
Narrative All viruses must self-assemble, a process which is controlled by the conformation and interactions of viral proteins. The proposed research is relevant to public health because a deeper understanding of the protein interactions that drive virus assembly will aid in development of novel anti-viral therapeutics targeted at virus assembly. Viruses also interact with their hosts during infection and studying virus:host interactions has revealed details about innate immunity systems that are evolutionarily conserved.